A Multidisciplinary Approach for Tow Truck Operator Safety

PROJECT SUMMARY
The automobile towing industry has an alarming average annual mortality rate of 43 fatalities per 100,000
workers, which is 15 times higher than the combined annual fatality rate of all other private industries. The high
fatality and injury rates in the towing industry were acknowledged at the National Occupational Injury Research
Symposium, emphasizing the need for research and prevention efforts. Struck-by incidents, particularly when
tow truck operators are on the side of the road and are hit by passing vehicles, are the leading cause of
fatalities and injuries among tow truck operators. Therefore, the overarching goal of the proposed research is
to identify interventions to reduce struck-by injuries and fatalities among tow truck operators. This goal aligns
with the National Institute of Occupational Safety and Health FY 2019-2026 strategic plan “Improve workplace
safety to reduce traumatic injuries”. The objective of this project is to develop a comprehensive understanding
of the underlying factors that contribute to struck-by incidents, informing the development of actionable
countermeasures and mitigation strategies. The central hypothesis is that the behaviors of tow truck operators
and passing drivers significantly contribute to struck-by incidents, influenced by factors such as laws and
regulations, law enforcement, and immediate road and traffic conditions. Our rationale is grounded in the
evidence that human behavior accounts for over 90% of traffic crashes, and therefore, it is likely the same for
struck-by incidents involving tow truck operators. The end goal will be achieved through three specific aims: 1)
assess state-level safety standards designed to protect tow truck operators; 2) investigate behaviors of tow
truck operators to identify factors affecting their vulnerability to vehicle strikes; and 3) explore behaviors of
passing drivers to identify factors contributing to struck-by incidents. The innovation of the project includes: 1) a
multi-method approach utilizing both quantitative and qualitative data collection techniques; 2) conducting
national surveys with law enforcement officers, tow truck operators, and passing drivers to understand and
compare their perspectives on tow truck operator safety; 3) comprehensive investigation of behaviors of tow
truck operators and passing drivers through field-based neurophysiological assessments and virtual reality-
based driving simulator experiments; 4) controlled and experimental methods to evaluate safety intervention
effectiveness; and 5) a multi-disciplinary team with experts from engineering, computer science, psychology,
policy, and road safety working towards a common goal of advancing tow truck operator safety. The proposed
research is a critical step in the systematic study of tow truck operator safety, as very little research has been
conducted on this topic to date. The results of this research have the potential to make a significant impact by
identifying safety interventions that can be translated into actionable items for policymakers, towing industry
leaders, and occupational safety promoters to improve the safety of tow truck operators.

Public health relevance
PROJECT NARRATIVE The automobile towing industry is one of the most dangerous jobs in the US, with the highest fatality rate among all private industries. Despite this, it has received little attention and research, as highlighted at the National Occupational Injury Research Symposium. This proposal addresses this gap by identifying interventions that could reduce the risk of struck-by traumatic injuries among tow truck operators, in alignment with the National Institute of Occupational Safety and Health 2019-2026 Strategic Plan (“Improve workplace safety to reduce traumatic injuries”).